Regulation of Soluble Adenylate Cyclase During Mammalian Sperm Capacitation

Approximately one-fifth of the world’s couples encounter fertility problems posing physical and emotional health
issues. While half of the infertility problems are attributed to the male, insufficient knowledge of sperm
physiology prohibits proper diagnosis in roughly 50% of these cases. A key aspect of fertilization involves
capacitation, a sperm maturation step within the female reproductive tract. In this step, the sperm acquires the
capacity to fertilize an egg, but many aspects of capacitation are still largely unknown. Our long-term goals are
to identify and characterize the mechanisms that regulate sperm capacitation. A key player in the capacitation
process is the soluble adenylyl cyclase (sAC), an enzyme that efficiently synthesizes cAMP when exposed to
bicarbonate and intracellular calcium. When sAC is activated, cAMP levels increase causing the sperm-specific
CatSper channel to open, allowing calcium to flow from the extracellular medium into the flagellum. So, how
does calcium initially reach sAC for its activation when CatSper is not yet active? Previous reports show that in
CatSper-null mice, cAMP levels can increase similarly to wild-type mice, suggesting that the initial calcium
influx does not occur as result of CatSper activation. Our preliminary data show that the initial calcium flow
indeed takes place in a CatSper-independent manner. Once sAC is activated, it remains active during the
whole capacitation process through an unknown regulation. Our preliminary data place Cdc42, a protein known
to control multiple cellular functions at the heart of this sAC regulation. While Cdc42 is expressed in
mammalian sperm, its role in this cell is unclear. Our central hypothesis is that sAC is differentially regulated to
allow both the initial activation that triggers capacitation and maintenance of sufficient cAMP levels throughout
the process. Aim 1 will identify a novel mechanism for the initial activation of sAC. Our hypothesis is that the
calcium required for the activation of sAC is delivered by ion channels present in the sperm head. Aim2 will
determine the role of Cdc42 on the activation of sAC during capacitation. Our hypothesis is that Cdc42 is
essential for cAMP production by sAC in the vicinity of the CatSper complex. These two aims will be achieved
by using super-resolution imaging to probe the localization of molecules within the flagellum, flow cytometry to
assess the activity of signaling molecules at the single-cell level, and patch clamp electrophysiology to
measure calcium currents. In addition, transgenic lines will enable us to abrogate CatSper channels and Cdc42
activity. The outcomes from this work will shed light on the initial activation of sAC, will identify the calcium
channel responsible for the first calcium influx during capacitation, and will elucidate the mechanism by which
sAC remains active in the same region of the CatSper signaling domain. We expect these fundamental
capacitation studies will open new avenues to find treatments of male infertility and aid in the development of
non-hormonal contraceptives.

Public health relevance
Approximately one-fifth of the world's couples encounter fertility problems, half of them being attributed to the male part. The main cause of this problem is attributed to an insufficient knowledge in sperm physiology at the molecular level. This project will use a cross-disciplinary approach to dissect the regulation of soluble adenylate cyclase in mammalian sperm with the goal of understanding unsolved physiological questions related to the acquisition of sperm fertilizing competence.